Information and Dissemination in Support of Community Interventions

ABSTRACT
The successful translation and dissemination of findings from alcohol prevention research into community-
based practice is a key component of the Environmental Approaches to Prevention Center Grant. Over the
past four years, Center Grant and other PRC staff members have sought to increase the awareness, adoption,
and implementation of effective strategies to reduce alcohol problems by implementing a widespread social
media release strategy through the Resource Link for Community Action of PRC, which is part of PRC's
website. The Resource Link provides information and practical guidance to state and community agencies and
organizations, policymakers, and members of the public who are interested in preventing or reducing alcohol-
and other drug-related harms. We have also expanded the audience for Center Grant and related research
conducted by PRC and other scientists by using social media such as Facebook, Twitter, and LinkedIn.
Although we have successfully broadcast findings from prevention research to a broad audience, key
questions remain about what types of informational content formats, delivered in what types of media
platforms, may be most useful to community-based governmental officials and advocates. Nor do we know the
extent to which they have noticed the information we have disseminated, much less how they may have used it
and with what audiences. For the next five-year Center Grant, and as informed by the implementation science
field, we propose an exploratory project to identify the most efficacious ways by which to translate our research
into practical and useful tools for community-based advocates and government officials. The specific aims of
this Information and Dissemination Component of the Center Grant are as follows: (1) Conduct discrete focus
groups with purposive samples of community-based (a) governmental officials (n=10) and (b) advocates
(n=10) to explore optimal content formats and social media platforms for the information we will disseminate
over the course of the next five years; (2) Using this input, develop a variety of policy-relevant informational
products that can be used by community-based advocates and local government officials nationwide; (3)
Conduct a media scan to identify a heterogeneous set of communities across the U.S. that have recently
experienced significant alcohol harm-related events, and identify key stakeholders in these communities who
are likely to have a substantial interest in identifying and implementing effective strategies to prevent further
harms; (4) In each of these communities, share our sample content formats and social media platforms to
determine which local stakeholders consider most useful; and (5) Assess stakeholders' receptivity to and
preferences for these various products and platforms, track whether and how they were used with which
audiences as well as how they were received, and disseminate findings from this project. We expect that these
activities will greatly enhance PRC's capabilities to successfully disseminate findings from studies conducted
as part of the Center Grant and from other alcohol prevention research at PRC.